National Health and Nutrition Examination Survey 2017-2018; Liver Ultrasound Elastography

Purpose: To provide support to the National Center for Health Statistics (NCHS) for the Liver Ultrasound Elastography Pilot Study in the National Health and Nutrition Examination Survey (NHANES).